A Cluster-Randomized Control Trial of a Workplace Resilience Intervention for Child Care Providers' Mental Health & Well-Being

ABSTR
ACT
Work-related stressors take a heavy toll on individuals’ health and well-being as made even more evident by the
increased awareness of essential workers during the pandemic and its still lingering impact on workplace settings
that already had the largest structural inequities. Resilience programs have arisen as a promising workplace
strategy to improve mental health and well-being for those at greatest risk; however, emerging programs are
limited by time- and resource-intensive in-person strategies limiting scalability and practicality for the most
marginalized of the workforce. Additionally, the literature on resilience programs are largely from preliminary
studies that lack of a priori sample size calculations, diversity of participants, and long-term maintenance
following the intervention, as well as inadequate control groups, which limits translation prompting calls for more
rigorous designs to evaluate the efficacy of these programs. Consistent with the aim of PAR-24-086 to test a
fully remotely delivered clinical trial with no in-person contact, this team has developed and translated the Stress
Management and Resilience Training (SMART) program for web-based delivery. Our pilot work demonstrates
feasibility, usability, satisfaction, and initial efficacy of the brief self-paced web-based learning sessions (1 hour
per week) with only 5-10 minutes of daily practice suggesting a fully powered study is timely and warranted. An
adequately powered, cluster randomized controlled trial to test the efficacy of the web-based SMART program
compared to a matched attention control in a high-need, diverse, and under-resourced and under-studied
segment of essential workers – childcare workers - will be conducted. Participants (640 childcare workers from
80 childcare centers) will be randomly assigned to either SMART or a matched attention control condition with
the primary outcome of mean change in resilience assets and resources (Connor-Davison Resilience Scale).
Measures will be collected at four timepoints: baseline (0 months), post-intervention (3 months), and long-term
maintenance (9 and 15 months). Secondary outcomes will include changes in overall mental health, negative
and positive mental health indicators, social support, and organizational assets and resources. Additionally, we
will explore potential moderators’ (e.g., sociodemographic, social determinants of health) influence on treatment
effects. The RE-AIM Framework will be used to determine reach and representativeness, and potential for
organizational level adoption, implementation, and maintenance of the SMART program. This study fills key
research gaps of previous resilience work in an underserved population in critical need of mental health and
well-being resources with implications for the feasibility and impact of remote programming in other marginalized
segments of the workforce.

Public health relevance
PROJECT NARRATIVE Resilience interventions are a promising strategy to improve individuals’ mental health and well-being; however, emerging models too often rely on time and resource intensive in-person trainings tested with still largely preliminary research designs limiting confidence in their scalability and impact. This project will use a rigorous clustered randomized controlled efficacy trial to test a fully remotely delivered resilience intervention targeting childcare staff, a high-risk group of essential workers. Results will provide guidance for a scientifically sound, replicable resilience intervention that can be rapidly translated to workplaces that are chronically affected by structural inequities.